How culture shapes memory strategies

PROJECT SUMMARY
Mnemonic strategy implementation has proven useful for cognitively healthy people but also for people with
episodic memory impairments due to normal aging, brain injuries, and neurodegeneration. Although recently there
has been emphasis on studying more diverse and representative samples in cognitive psychology and neuroscience,
little research has applied a cultural approach to study memory strategies. Culture can shape the way one thinks about
the self, known as self-construal, which can have major implications for cognition. Thinking about the self can
enhance memory via the self-reference effect, a strategy that relies on relating information to oneself. Context
features of to-be-encoded events that can be used to enhance episodic memory may be attended to differently
across cultures, potentially affecting episodic memory. However, the mechanisms by which culture impacts the
effectiveness of these memory strategies has not been investigated. We address this gap in the literature by
investigating multiple cultural groups in the U.S.
The specific aims of the project are to advance understanding of how self-referencing and context impact memory,
as well as the neural activity that supports these benefits in memory, in culturally diverse samples. An independent
self, considered separate from and unique from others, characterizes non-Hispanic White samples whereas
Chinese and Latino samples tend to be more interdependent, conceptualizing the self in terms of relationships
with others. We will test to what extent cultural group and associated factors impact self-reference and context
effects in episodic memory in non-Hispanic Whites, 2nd generation Chinese Americans, and 2nd generation
Mexican Americans, the two largest racial and ethnic minority groups in the U.S; thereby moving beyond the East-
West comparisons typical of culture work. Although these 2nd generation groups have many aspects of self-
construal in common, there are important differences, such as emotional expressivity. We will explore culture
group differences in the content of episodic memories, and the potential heterogeneity of 2nd generation samples
by considering the roles of cultural and language identity, and stress on memory outcomes. We will measure
behavioral memory performance and brain activity during episodic encoding and retrieval (ERP and Encoding-
Retrieval Similarity Analyses) to distinguish mechanisms of strategy implementation from processes specific to
memory success, allowing us to understand how culture impacts episodic memory.
Not only will the project diversify and expand our study populations but should the effectiveness of these memory
strategies depend upon culture, it would suggest a need to update and advance current memory theories to
incorporate the influence of these factors. Furthermore, understanding cultural differences in the use of memory
strategies can support effective cognition and independence across the lifespan, revealing who may have the most
difficulty implementing such strategies and identifying reasons why, informing future interventions.

Public health relevance
Project Narrative The proposed research contributes to public health by investigating the ways in which culture impacts memory and brain activity. Cross-cultural comparisons are needed to have accurate understanding of how memory works and whether strategies are equally effective across groups. Understanding cultural differences in the use of memory strategies can inform the development of effective interventions to maintain memory function with aging and Alzheimer's disease, to improve cognition in diverse populations.